Effects of chronic use of thickened liquids in a rat model of aging

Abstract
Swallowing disorders are highly prevalent in elderly people, including those with age-related diseases.
Thickened liquids are frequently used in the treatment of swallowing disorders and have been shown to
immediately reduce the chance of airway invasion. However, thickened liquids have been associated with
deleterious health effects such as dehydration, urinary tract infection, and reduced quality of life. Despite their
common clinical use, the long-term efficacy of thickened liquids, and their effect on swallowing kinematics,
systemic hydration, and underlying biology, is not well understood. Given the rapidly increasing population of
persons over 65, estimated to reach 2.1 billion by 2051, it is critical to understand the efficacy of dysphagia
interventions. The overarching goal of this proposal is to contribute foundational knowledge of biological
mechanisms underlying functional swallowing changes in response to a frequently used, but understudied,
intervention for dysphagia management in the aging population. The proposed study will use an aging rat
model to interrogate how use of thickened liquids affects swallowing kinematics, systemic hydration, and
underlying biology over time. We have 3 specific aims, each with a unique hypothesis. Aim 1 will test the
hypothesis that chronic use of thickened liquid textures reduces bolus speed, reduces coordination of
swallowing muscles, and disrupts normal respiratory-swallow event sequencing. Aim 2 will test the hypothesis
that thickened liquids result in reduced volume of fluid intake and systemic dehydration, which will be
exacerbated by viscosity and age. Aim 3 will test the hypothesis that thickened liquids, in the absence of thin
liquid, will slow swallowing movements, dynamically altering muscle contractile properties to include reduced
tongue forces and increased contraction times in an age-dependent manner. In concert, the proportion of fast-
contracting type IIb myosin heavy chain (MyHC) isoforms in the tongue will be reduced, causing an increased
proportion of slower-contracting isoforms, such as type IIa and type I. This research is highly significant in that
it will be the first in an aging animal model to examine the effects of thickened liquids on systemic hydration
along with underlying muscle biology, kinematics, and physiology, and the relationship to clinically relevant
outcome measures of swallow function. Knowledge gained from this work will lead to hypotheses for testing in
clinical studies that are crucial for clinical decisions that must balance patient risk of aspiration and subsequent
medical complications, against the impact of potential deleterious effects of thickened liquids on patient overall
medical status and quality of life.

Public health relevance
Project Narrative The use of thickened liquids to prevent aspiration is a common clinical intervention for swallowing disorders, but the underlying mechanisms by which thickened liquids achieve this airway protection, and how the swallowing system responds to thickened liquids over time and with aging, remain poorly understood. The goal of the proposed study is to determine the effects of thickened liquids on swallowing and underlying biology, systemic hydration, and interactions with aging. Findings of this study will contribute significantly to identifying mechanisms and long-term risks and benefits of thickened liquid use.